Direct picogram DNA and RNA sequencing using nanopore Zero-mode waveguides

PROJECT SUMMARY Per the FOA, this document is not required.

Public health relevance
PROJECT NARRATIVE Per the FOA, this document is not required.